Functional consequences of fetal-alcohol-induced brain growth abnormalities identified with in utero MRI

PROJECT SUMMARY
Fetal exposure to alcohol leads to a wide range of neurological deficits collectively termed fetal alcohol
spectrum disorder (FASD). This prevalent neurodevelopmental disorder currently affects as many as 1-5% of
school-aged children in the United States. Existing intervention strategies can improve the quality of life in
affected individuals, but early detection is critical for efficacious therapy. In utero MRI has benefited from recent
improvements in retrospective motion correction methods in 3D image reconstruction, and is a promising non-
invasive technique for identifying abnormal brain development associated with fetal exposure to alcohol. We
have recently developed a rhesus macaque model of FASD that resembles human drinking early in gestation,
prior to pregnancy awareness, but ceases upon recognition of pregnancy. Abnormal brain growth is apparent
at gestation day (G)135 by MRI in fetuses of rhesus macaques that orally self-administered 1.5 g/kg
(approximately 6 drinks) daily ethanol over the first 60 days of pregnancy. Compared to controls, ethanol-
exposed fetuses possessed brains with smaller cerebellums and less developed white matter fiber systems
involved in motor and cognitive function. Ex vivo electrophysiological recordings performed on the G135
fetuses demonstrated that the MRI-identified abnormalities are associated with functional impairments in
glutamatergic transmission. The experiments proposed in this application will determine the behavioral
consequences of these anatomical and functional abnormalities, and further extend the MRI and
electrophysiological characterization of this model of FASD. Twelve rhesus macaques exposed to daily
maternal 1.5 g/kg ethanol drinking over the first 60 days of gestation will be compared to 12 control animals. In
utero MRI will be performed at G135, and the offspring will be survived to postnatal day (P)180 (approximately
6 months of age). Additional MRI experiments will be performed on P3 and P180. Aim 1 of this proposal will
use fetal (G135) and postnatal MRI (P3 and P180) to define the long-term impact of ethanol exposure on brain
development. This Aim includes a primary analysis focused on brain structures identified to be different at
G135 and whole-brain analysis to define additional brain regions sensitive to fetal ethanol exposure. These
results will facilitate data reduction for the combined analyses with other experimental modalities in Aims 2 and
3. Aim 2 will examine impairments in motor behavior due to fetal ethanol exposure and define the underlying
neural circuitry. Aim 3 will define the impairments in cognitive function and emotional regulation induced by
fetal ethanol exposure and identify the developmental processes and specific brain regions associated with
these impairments.

Public health relevance
PROJECT NARRATIVE Therapeutic intervention for fetal alcohol spectrum disorder (FASD), a highly prevalent neurodevelopmental disorder in the United States, is most effective if initiated early. The research proposed here will use a nonhuman primate model of FASD to develop in utero and neonatal MRI methods for detecting brain abnormalities and predict the severity of behavioral impairments associated with fetal exposure to alcohol. Studies of neural activity in the brains of ethanol-exposed animals will provide an understanding of the neurocircuitry involved in behavioral impairments associated with FASD, and guide the interpretation of fetal and neonatal MRI findings.